Spatial diversity of GPCR-mediated ERK signaling and its role in cardiovascular disease

Project Summary
G-protein-coupled receptors (GPCRs), the largest family of membrane receptors, play a key role in maintaining
heart function1,2. In particular, β1-adrenergic receptor (β1AR) contributes to normal cardiac function including
regulation of heart rate and contractility, but its overstimulation by circulating catecholamines such as adrenaline
and noradrenaline can induce cardiac hypertrophy, leading to heart failure3-6. Recent findings reveal that β1ARs
are not only active at the plasma membrane but are also localized on the Golgi membrane of cardiac myocytes,
activating the cAMP/PKA pathway and regulating PLCε-mediated cardiac hypertrophy in NRVMs11. A major
downstream signaling component of β1AR is Extracellular Signal-Regulated Kinase (ERK), a master regulator of
cell survival, growth, and metabolism9. Although ERK activity has also been implicated in cardiac hypertrophy10,
the mechanism underlying β1AR-mediated ERK activation and how it contributes to cardiac hypertrophy are still
not well understood. In preliminary studies, I showed that distinct pools of adrenaline-activated β1ARs can
activate ERK at the plasma membrane and the Golgi, respectively, suggesting that the β1AR-ERK signaling is
also spatially regulated. The subcellular pools of β1AR were also found to regulate the downstream ERK
activation via different mechanisms - through the Gβγ complex of heterotrimeric G proteins and β-arrestin for
plasma membrane and Golgi ERK respectively. Additionally, only the plasma membrane pool of β1AR propagated
ERK activity into the nucleus, establishing a novel spatial diversity in GPCR-effector protein coupling
mechanisms that could have major implications for the role of ERK in cardiac physiology. Thus, the overarching
hypothesis of the proposed project is that the coordination of ERK activation by distinct subcellular pools of
β1ARs regulates cardiac hypertrophy. The project will have two aims consisting of (1) illuminating the spatial
organization of β1AR-mediated ERK activation at subcellular compartments, and (2) studying the functional
impact of compartmentalized β1AR-mediated ERK signaling on cardiac hypertrophy. These aims will be tested
using fluorescent biosensor imaging, targeted biochemical perturbations, and cellular assays in cardiomyocytes.
The proposed studies will elucidate the mechanisms of compartmentalized β1AR-mediated ERK signaling and
provide a better understanding of their critical roles in regulating cardiac health, paving the way for novel
therapeutic strategies.

Public health relevance
Project Narrative We are studying a major signaling pathway, β1AR-mediated ERK signaling, and its critical role in regulating cardiac health and disease such as in cardiac hypertrophy. Though previous studies have highlighted the participation of β1AR and ERK in driving cardiac hypertrophy, our understanding of where and how β1AR activates ERK in cardiac myocytes to promote cardiac hypertrophy is minimal. The proposed work seeks to provide a better understanding of how β1AR tightly controls ERK activity in the context of heart function and failure.